Mentoring in Immunometabolic Dysregulation in TB and TB/HIV

Tuberculosis (TB) is the leading cause of death among people living with HIV (PLWH) worldwide. Despite
recent scientific advances, significant gaps remain in our understanding of the immune mechanisms
responsible for control and eradication of Mycobacterium tuberculosis (Mtb) infection. PLWH with latent TB
infection (LTBI) have a ~10% annual risk of progressing to TB disease, however currently available tests for
LTBI diagnosis have reduced sensitivity in this population and are not able to predict which latently infected
individuals are at highest risk for developing TB for targeted preventive therapy. Emerging data from
clinically relevant animal models suggest that LTBI and active TB represent a spectrum of immune
responses and host pathology, with increasing metabolic changes and immune dysregulation during the
transition to TB disease. We have identified unique serum metabolite and microRNA (miRNA) profiles that
are able to discriminate between patients with TB and those with non-TB lung disease. However, these
novel TB signatures have not been assessed prospectively to identify PLWH and HIV-negative persons with
LTBI who are at increased risk for TB progression. In order to address this significant knowledge gap, in Aim
1 of the current research program, trainees will leverage the Indian and South African RePORT longitudinal
biorepositories of household contacts of TB index cases to test the hypothesis that TB is a chronic
inflammatory disease associated with profound changes in immune regulation and metabolism prior to the
onset of clinical signs and symptoms. Another major barrier to global TB eradication efforts is the lengthy
and complicated current anti-tubercular regimen, which is associated with medical nonadherence and the
emergence of drug resistance. Recently, attention has focused on host-directed adjunctive therapies aimed
at optimizing immune responses to the pathogen and improving lung damage. Lipid-laden macrophages
(foam cells) are central to maintaining chronic TB infection by providing a favorable niche in which
antimicrobial functions are down-regulated, and by inducing caseation and tissue damage. Recent work has
shown that foam-cell-rich and necrotic areas of TB granulomas are particularly enriched in triglycerides. Mtb
infection is associated with dysregulation of two cellular pathways involved in triglyceride homeostasis: a
pro-lipogenic pathway involving protein kinase B and mTOR complex 1 (Akt/mTORC1), and an anti-
lipogenic pathway involving AMP-activated protein kinase and the sirtuins (AMPK/SIRT). In Aim 2, trainees
will use longitudinal clinical samples from RePORT study participants and experimental infections ex vivo to
characterize: (i) the relationship between activation of these pathways and control of clinical Mtb infection,
and the effect of anti-lipogenic treatments on antimycobacterial functions of human macrophages infected
ex vivo. The research aims will be integrated with a mentoring strategy for mentees that fosters
development of high impact patient-oriented research with a pathway to independence.

Public health relevance
Tuberculosis (TB) remains among the most deadly infections worldwide, especially among people living with HIV. Current available tests are not able to accurately detect persons at the highest risk of developing TB, and curing the disease requires at least 6 months of therapy because the TB bacteria can avoid being killed by the immune system and currently available drugs. In the current proposal, physician scientists will receive training in a variety of complementary disciplines, and use several cutting-edge experimental and modeling techniques to analyze samples from patients with TB and TB/HIV, with the ultimate goal of identifying new biomarkers that can predict TB disease and host-directed therapies that can shorten TB treatment.